The Healthy Brain and Child Development National Consortium Administrative Core

PROJECT SUMMARY/ABSTRACT
Opioid use during pregnancy is widespread and associated with adverse outcomes for the pregnant individual
and the developing child, including reduced fetal growth, premature birth, lower birth weight, congenital defects,
increased neonatal healthcare, and heightened risk for later behavioral (e.g., anxiety, inattention), cognitive (e.g.,
memory deficits, delayed language acquisition), and metabolic problems. Despite opioid use being linked to
adverse maternal, fetal, and child outcomes, the mechanisms through which these arise and the potential
consequences of prenatal opioid exposure for child health and development (e.g., brain and behavior) remain
largely unexplored. This lack of etiologic knowledge has contributed to stagnant treatment, prevention, and
mitigation efforts leaving individuals and families susceptible to reverberating adverse outcomes. The HEALthy
Brain and Child Development (HBCD) Study is a 25-site longitudinal prospective study of early child development
in the US that will assess a broad spectrum of biological (e.g., neuroimaging, genetics, epigenetics), behavioral
(e.g., cognition and emotional regulation), experiential (e.g., trauma), social (e.g., racism), and health (e.g.,
psychopathology) factors among ~7,500 nationally-representative pregnant women and their children from
pregnancy to mid-childhood. A major goal of the HBCD Study is to increase understanding of the potential
consequences of prenatal substance exposures. It will be enriched for maternal substance use during pregnancy
(i.e., ~25% of the sample will be using opioids, cannabis, alcohol, and/or tobacco during pregnancy) and offers
a unique opportunity to inform our understanding of how the adverse consequences associated with opioid use
during pregnancy arise. Although HBCD will be the largest long-term study of early brain and child development
outcomes in the US, the core protocol does not include the collection of delivery biospecimens. This
Administrative Supplement in response to the NIDA/ORWH Administrative Supplement Notice of Special
Interest: HEAL Initiative: Biospecimen Collection in Pregnancy (NOT-DA-23-005) proposes to leverage the
HBCD Study by expanding the biospecimen collection of the Core HBCD Protocol to include delivery specimens
(placenta, cord tissue, cord blood). Delivery samples will be collected from a sample of HBCD Study participants
across up to 14 HBCD sites (encompassing over 2,000 participants) who have submitted applications in
response to this NOSI. This will provide an unprecedented resource generating opportunity for the larger
scientific community to comprehensively evaluate pathophysiological mechanisms that mediate the connection
between opioid and polysubstance use during pregnancy and adverse neonatal, infant, and/or maternal health
outcomes and, in turn, inform innovative preventive strategies.

Public health relevance
PROJECT NARRATIVE This Administrative Supplement to the large national longitudinal study – the HEALthy Brain and Child Development (HBCD) Study, will expand biospecimen collection of the Core HBCD Protocol to include delivery specimens (placenta, cord tissue, cord blood) for over 2,000 participants. This will provide an unprecedented resource generating opportunity for the larger scientific community to comprehensively evaluate pathophysiological mechanisms that mediate opioid and other substance use during pregnancy and adverse neonatal, infant, and/or maternal health outcomes, and, in turn, inform innovative preventive strategies.